CONFERENCE--PHYSIOLOGY AND PHARMCOLOGY OF MOTOR CONTROL

The APS Conference on the "Physiology and Pharmacolgy of Motor Control," is scheduled for October 2-5, 1993, in San Diego, California. In selecting the topic, the American Physiological Society (APS) was reflecting on the fact that movement is one of the main extrinsic actions of the brain, representing the orchestrated activity of many neurons. The integrative action of these neurons and their neurotransmitters is critical in the generation and control of this complex behavior. The goal of the APS Conference and this proposal is to bring together neuroscientists with special interests in neuropharmacology and/or control of movement to explore the frontiers of their respective specialties and the possibilities of applying what is known about the neuropharmacology of single neurons to the complex problem of motor control. The symposia associated with this APS Conference address areas of uncertainty and/or controversy, as well as their fundamental importance. The interdisciplinary group of investigators participating in the symposia have such breadth and depth of knowledge in the physiology and pharmacology of motor control that the conference should yield new insights in the field and serve to stimulate the interest of students and young scientists. The inclusion of free communications in the APS Conference will allow for cross-fertilization of ideas between the speakers and the attendees. This Conference will focus on different aspects of neuropharmacology and/or the central control of movement.